VERY LOW CALORIE DIETS AND EXERCISE IN OBESITY TREATMENT

Determine the effects of calorie restriction alone or calorie restriction with weight training on body composition, muscle fiber size and type, energy expenditure, and the energy cost of exercise.